Using allopregnanolone to probe behavioral and neurobiological mechanisms that underlie depression in women across perimenopausal stage

PROJECT SUMMARY
Women are twice as likely as men to develop depression, and among some women, reproductive transitions
trigger unique hormonal risks for reproductive-endocrine mood disorders. Changing reproductive steroid
dynamics contribute female-specific endocrine risk factors in postpartum depression (PPD), premenstrual
dysphoric disorder (PMDD), and perimenopausal depression (PeriDep). However, PeriDep lags far behind PPD
and PMDD, each of which has FDA-approved therapies that leverage the reproductive endocrine changes
underlying hormonally-linked depression. For example, the neurosteroid allopregnanolone (ALLO) in its
proprietary form brexanolone has proven antidepressant efficacy for PPD. Endogenous ALLO levels decline
after delivery, as women traverse menopause, and are lower in women with than without depression. Despite
parallels to PPD, and despite the large population potentially affected by PeriDep—approximately 5.4 million
women are perimenopausal annually—the contributions of ALLO to PeriDep have not been investigated. Key
pilot data show a protective benefit of the ALLO precursor progesterone (P4) in PeriDep and that P4 correlates
with advantageous neuroprotective, inflammatory, and neurophysiologic sleep profiles, all known ALLO targets.
Thus, this project will use a mechanistic placebo-controlled trial to uncover the behavioral and neurobiological
mechanisms through which ALLO exerts its therapeutic effects in women with PeriDep. Specifically, the project
will examine key mechanistic targets underlying depression to include behavioral (Aim 1a: rumination, negative
attentional bias), circuit-based (Aim 1b: functional connectivity within default mode network and between default
mode and salience networks), molecular (Aim 2a: circulating and magnetic resonance spectroscopy neurotrophic
and pro-inflammatory molecules), and physiological (Aim 2b: sleep EEG wake after sleep onset) outcomes.
Eighty women with mild to severe PeriDep will be randomized to double-blinded placebo or ALLO administered
as a 60-hour brexanolone infusion, stratified by early vs. late perimenopausal status. Analyses will test the acute
(immediately post-treatment) and durable (30-days post-treatment) effects of ALLO on each of the selected
mechanistic outcomes, mirroring the efficacy and biological data in human and animal models of PPD. Results
will be integrated (Aim 3) to determine how each mechanistic outcome mediates ALLO’s effect on global
measures of depression severity and to examine modification by depression illness course and early vs. late
perimenopausal status. This innovative project pairing a mechanistic intervention with robust behavioral and
neurobiological outcomes will exploit mechanistic pathways underlying the role of ALLO in PeriDep and translate
findings to identify novel therapeutic targets that are specific for PeriDep.

Public health relevance
PROJECT NARRATIVE Depression is common during perimenopause and is linked to changes in female steroid hormones that underlie reproductive transitions. While perimenopausal depression shares several risk factors with other depressive disorders, its unique hormonal underpinnings have not been harnessed as a potential targeted treatment. Our study will identify how the progesterone metabolite allopregnanolone affects behavior and neurobiology that may underlie perimenopausal depression, as an approach to develop specific and effective interventions for perimenopausal depression.